SELVA: A Multicenter, Phase 3 Baseline-Controlled Study Evaluating the Safety and Efficacy of PTX-022 in the Treatment of Microcystic Lymphatic Malformations

FOA Number: RFA-FD-23-001
FOA Title: Clinical Studies of Orphan Products Addressing Unmet Needs of Rare Diseases (R01) Clinical Trials
Required
Proposal Title: SELVA: A Multicenter, Phase 3 Baseline-Controlled Study Evaluating the Safety and Efficacy of PTX-
022 in the Treatment of Microcystic Lymphatic Malformations
Institute: FDA Office of Orphan Products Development
Study Section: N/A
Summary
The objective of this project is to demonstrate the safety and efficacy of PTX-022 (sirolimus) Topical Gel 3.9% w/w for
patients suffering from microcystic lymphatic malformations (microcystic LM). Microcystic LM is a serious, rare, and
chronic disease of the lymphatic system characterized by lymphorrhea, acute cellulitis and significant patient morbidity.
Microcystic LM is an orphan disease with no FDA approved therapies and there is an urgent need to develop the first
FDA approved therapy to treat this debilitating disease.
Microcystic LM is usually present at birth or shortly after, with the pathology often originating in the dermis and
protruding out through the epidermis and stratum corneum. Recent studies have identified that patients with microcystic
LM have postzygotic mutations in PI3K leading to abnormal and increased activation in mTOR signaling as well as its
downstream target vascular endothelial growth factor (VEGF). Oral sirolimus, an mTOR inhibitor which is also known as
rapamycin, has demonstrated preliminary benefit in patients with microcystic LM but its use is limited by the adverse
event profile, requirement for frequent blood monitoring, and limited distribution to the skin. Therefore, Palvella
Therapeutics, Inc. (Palvella) is developing PTX-022, a 3.9% topical sirolimus gel designed to deliver high levels of
sirolimus directly to the site of disease, the epidermis and dermis, while avoiding the systemic side effects of oral
sirolimus. PTX-022 recently completed a Phase 2, 12 patient, open-label clinical study (NCT05050149). Efficacy data
from the Phase 2 study demonstrated statistically significant and clinically meaningful improvements with patients treated
with PTX-022. All twelve patients who entered the study were either “much improved” (n=7, 58%) or “very much
improved” (n=5, 42%) on the clinician global impression of change (CGI-C) and all twelve patients improved on the
patient global impression of change (PGI-C).
Based on the Phase 2 data, FDA awarded PTX-022 Breakthrough Therapy Designation for the treatment of microcystic
LM. Breakthrough Therapy Designation is intended to expedite the development and review of therapies for serious or
life-threatening conditions and whose preliminary clinical evidence indicates that the drug may demonstrate substantial
improvement on one or more clinically significant endpoints over existing therapies. Following a collaborative Type B
Meeting with FDA in April 2024, Palvella is advancing the development of PTX-022 into a registrational Phase 3 study in
patients with microcystic LM. Primary efficacy will be assessed using a fit for purpose microcystic LM Investigator
Global Assessment (mLM-IGA) scale. The secondary objectives are to determine the efficacy of once-daily treatment
with PTX-022 utilizing scores from the clinician microcystic LM multicomponent severity scale, the overall patient global
impression of change (PGI-C) scores, and the overall clinical global impression of severity (CGI-S) scale. Importantly,
exit and entry qualitative interviews will be conducted for each patient to determine burden of disease and clinical
meaningfulness of any changes observed.
In addition to Breakthrough Designation, PTX-022 has been granted Fast Track Designation and Orphan Drug
Designation by the FDA for microcystic LM. Grant funding, if awarded, will be used to directly support the initiation,
enrollment, and completion of the Phase 3 clinical trial and support NDA submission and FDA approval. This proposal
aims to fulfill the goal of the FDA’s Office of Orphan Product Development grant program to support the clinical
development of products for use in rare diseases where no therapy currently exists.

Public health relevance
FOA Number: RFA-FD-23-001 FOA Title: Clinical Studies of Orphan Products Addressing Unmet Needs of Rare Diseases (R01) Clinical Trials Required Proposal Title: SELVA: A Multicenter, Phase 3 Baseline-Controlled Study Evaluating the Safety and Efficacy of PTX- 022 in the Treatment of Microcystic Lymphatic Malformations Institute: FDA Office of Orphan Products Development Study Section: N/A Project Narrative This application proposes to develop a novel pathologically targeted therapy for a rare genetic disease called microcystic lymphatic malformations (microcystic LM). Microcystic LM is caused by mutations in the PI3K/mTOR signaling pathway, resulting in abnormal lymphatic vessel formations that result in cutaneous lesions. Palvella Therapeutics plans to treat microcystic LM with PTX-022, a topical gel that targets the root cause of microcystic LMs, by downregulating excessive mTOR signaling at the site of disease.